Housing Scientific Working Group

PROJECT SUMMARY FOR HOUSING SCIENTIFIC WORKING GROUP
The HIV epidemic is inextricably linked with factors disproportionately common in low-income populations,
including food insecurity, violence, incarceration, racism, substance use, post traumatic stress disorder
(PTSD), and depression. Each of these factors significantly increases the risk of HIV infection, creates barriers
to testing and health care, and makes negative health outcomes much more likely. The issue at the center of it
all is homelessness, which magnifies the likelihood of every other risk factor. Homelessness and unstable
housing (HUH) have been recognized as major barriers to reducing HIV incidence and improving HIV viral
suppression for over two decades, and continue to impede Ending the HIV Epidemic goals. As the housing
crisis worsens in the San Francisco Bay Area and across the country, new approaches to health care delivery
and research aimed at improving strategies to address disparities in HIV outcomes by housing status are
critically needed. We therefore have formed a new UCSF-Bay Area CFAR Scientific Working Group (SWG),
which will serve as a hub for individuals across the San Francisco Bay Area researching ways to improve HIV
care engagement, treatment and prevention outcomes among people experiencing HUH. While there is a
wealth of San Francisco Bay Area expertise in areas critical to, overlapping and adjacent to those influencing
health outcomes in the context of HIV and housing, there is currently no forum for cross-disciplinary pollination
and collaboration. Our proposed SWG in the UCSF Bay Area CFAR will provide an environment and platform
that intentionally and regularly brings together researchers, community stakeholders, implementers, and
policymakers to explore synergies and foster collaboration.
This new Scientific Working Group on Housing and HIV will create opportunities to share ideas across
academic disciplines, as well as between academia, the community, policy makers, and agencies delivering
services. We will provide forums, symposia and workshops to comprehensively evaluate the existing evidence
on how to improve HIV prevention and treatment outcomes among people experiencing marginal housing, and
how this research might be implemented in novel ways; identify gaps in the existing knowledge base; develop
new study ideas and new approaches to research; and disseminate work in the area of HUH and HIV. We will
work closely with other Cores in the CFAR, including the Bio-Behavioral and Developmental Cores, and with
the Intersectionality Scientific Working Group on initiatives to improve the health of those with HIV or at risk of
HIV and marginal housing. This work will extend to the international arena through the areas of migration,
mobility, and homelessness. Domestically, this novel SWG will rally expertise across UCSF and our affiliates,
including the San Francisco Department of Public Health, to work on End the HIV Epidemic goals.